Senolytics to Improve Cognition and Mobility in Older Adults at Risk of Alzheimer’s Disease

Project Summary:
Abnormalities in cognition and mobility are common accompaniments of aging that often
precede the development of Alzheimer's disease. Among their many etiologies, these
abnormalities are associated with alterations in the regulation of cerebral blood flow to frontal
regions of the brain that subserve executive functions and gait speed. We have previously
shown that treatment with cocoa flavanols can improve blood flow in response to a cognitive
task (neurovascular coupling [NVC]), as well as executive function in older people with impaired
NVC. These compounds can also reduce the number of senescent cells and their toxic
secretory products (SASP) in a variety of tissues. In mice, “senolytic” compounds such as
flavanols and tyrosine kinase inhibitors, have been shown to reduce neurofibrillary tangle
density, neuron loss, and ventricular enlargement, and in humans with idiopathic pulmonary
fibrosis, improve gait speed and other functional abilities. Based on these findings, we
hypothesize that the flavanol, Quercetin, and tyrosine kinase inhibitor, Dasatinib, (Q+D) will
improve NVC in response to an executive task, reduce circulating SASP components, and in so
doing, improve cognition and mobility in older adults who are at risk of Alzheimer's disease.

Public health relevance
Project Narrative: The long-term goal of this study is to prevent common age-related impairments in cognition and mobility that lead to the development of Alzheimer's disease by interrupting one of the fundamental mechanisms of aging, namely the accumulation of senescent cells and their damaging products. We will determine the feasibility of administering Quercetin and Dasatinib to eliminate these cells from the body, and test whether their elimination can improve brain blood flow, cognition, and mobility in older adults at risk of developing Alzheimer's disease.